Translational Research Support Core

SUMMARY: TRANSLATIONAL RESEARCH SUPPORT CORE
The vision for the Translational Research Support Core (TRSC) of the Gulf Coast Center for Precision
Environmental Health (GC-CPEH) is to improve environmental health by promoting translation of laboratorybased
research into population studies and facilitating “reverse translation” of research in community and clinical
settings into new hypothesis-driven research. The TRSC leverages resources and talent from GC-CPEH parent
institutions and supports translational environmental health sciences (EHS) research in three Thematic Focus
Areas: Genome and Epigenome Environment Interactions (GE2); Mechanisms and Interventions for Human
Environmental Disease (MIHED), and Current and Emergent Environmental Threats (CEET) to human health.
The TRSC provides centralized expertise, resources, and capabilities, combined with seamless access through
the TRSC Web portal, and supports workshops and symposia that increase the environmental health impact of
GC-CPEH members. Translational Navigators provide subject matter expertise and prioritized access to TRSC
resources and capabilities, and the Matching Funds Core Utilization Program increases cost-effectiveness
and utilization of TRSC services. The TRSC creates powerful synergy with other components, including: 1) the
Thematic Focus Areas by promoting forward and reverse translation of member research; 2) the Pilot Project
Program by providing guidance and capabilities for translational research approaches into pilot project
applications; and 3) the Administrative Core through tracking of member usage and outcome metrics, surveys
for service and capability needs, subsidies from the Matching Funds Core Utilization Program, and participation
in the Leadership Development Program. As a bridge between bench- and population-based researchers, the
TRSC promotes and sustains collaborations that contribute to high-impact publications and acquisition of
extramural grants supporting EHS research. Working with the Community Engagement Core (CEC), the
TRSC facilitates forward and reverse translation of member research with community partners and decision
makers to improve human environmental health. The TRSC and CEC cooperatively provide strategic support
for research, educational, and outreach activities on emerging health threats. Specific Aims for the TRSC are:
Specific Aim 1: Provide services and resources that foster translation between laboratory-based and clinical
and population health research; Specific Aim 2: Enhance translational EHS research by members via
integration with other GC-CPEH components and facilitating impactful collaborations; Specific Aim 3: Enhance
basic and population based translational EHS research by facilitating interactions between researchers and
community partners and decision makers.